Development of a Novel EMG-Based Neural Interface for Control of Transradial Prostheses with Gripping Assistance

PROJECT SUMMARY
An upper limb amputation can make many basic tasks difficult or nearly impossible. In recent years, research in
algorithms that can predict motion intentions from electromyographic (EMG) signals of a residual limb has led to
the development of prosthetic hands that allow control of multiple degrees of freedom (DOF) and has restored
the basic functionality of an upper-limb. Some of the most advanced commercially available prosthetic hands
use a machine learning-based control scheme known as EMG pattern recognition (PR). Many EMG PR
approaches predict a motion class (e.g. hand open/close) and set the velocity of the motors proportional to the
magnitude of EMG signals. Some new proposed approaches involve simultaneously controlling the position of
multiple DOF. However, all of these control schemes allow users minimal control of the force applied to objects
grasped by the prosthetic hand which makes holding and transporting fragile objects difficult.
The overall objective of this project is to develop a novel control scheme that allows simultaneous control of the
positions of multiple DOF of a transradial prosthesis as well as control of grip force when an object has made
contact with the fingertips of the prosthesis. To achieve this objective, this proposal consists of the following 2
aims: 1) Develop a novel shared control framework for real-time upper limb prosthesis control and gripping and
2) Evaluate the performance and cognitive workload of the shared control framework. The shared controller will
use an artificial neural network (ANN) to map the features of EMG signals to joint torque and a forward dynamics
model to calculate joint kinematics. EMG and joint motion data will be collected from subjects and a reinforcement
learning algorithm will be used to train the ANN to minimize the error between estimated and measured joint
positions. A force sensor attached to the fingertip of a prosthetic hand will detect when contact with an object
has been made and measure the grip force. The estimated torque of the metacarpophalangeal (MCP) joint will
be used to estimate a desired grip force and a PID controller will drive the measured grip force to this desired
grip force. To evaluate the framework, a virtual task will be used to test a subjects’ ability to control the grip force
of the hand by having them follow a given force trajectory displayed on a monitor. Then, subjects will use both
the shared controller and EMG PR to complete 2 functional tasks involving transporting fragile/deformable
objects. Tasks will be completed with and without a mentally demanding dual task and the differences in
performance will be used to estimate cognitive loads.
This proposed work is expected to introduce a method of controlling transradial prostheses that provides reliable
position-based control of multiple DOF and precise control of the grip force the prosthetic hand applies to objects
with various levels of compliance. This method can reduce the difficulties and mental demands of object grasping
tasks and lead to a higher acceptance rate of powered upper limb prostheses.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Potential improvements to the control of upper limb prostheses from electromyographic (EMG) signals have been researched for years in an attempt to improve the quality of life of amputee patients. This proposal aims to develop a control scheme that allows reliable and intuitive object gripping. The outcomes of the project will increase the usability of transradial prostheses for holding and transporting fragile objects.